TO MODIFY THE CONTRACT AND ADD ADDITIONAL FUNDING TO CONFIGURE A SMARTPHONE AND WEB-BASED DIGITAL HEALTH SOLUTION TO SUPPORT THE GENERAL PUBLIC USE OF

The National Institute of Biomedical Imaging and Bioengineering (NIBIB) requires a system that can be managed by a study team and that will support general public use of SARS-CoV-2 diagnostic tests performed in a home setting. The platform must be easily accessible on a mobile device, support a variety of surveys, display test-specific usage instructions, provide guidance to the user on actions to take following test results, provide reminder notifications for test frequency, record the test results, integrate with technologies that provide test interpretation (as available), and report results to public health authorities as applicable and authorized by the user. It must additionally make all these data available to the study team for future analysis, when this is within the remit of the IRB approval for the study.